Combinatorial Chemistry and Chemical Biology Shared Resource

COMBINATORIAL CHEMISTRY AND CHEMICAL BIOLOGY SHARED RESOURCE (CCCBSR)
PROJECT SUMMARY/ABSTRACT
The Combinatorial Chemistry and Chemical Biology Shared Resource (CCCBSR) provides outstanding
services and expertise on rapid lead discovery through one-bead one-compound (OBOC) and one-bead two-
compound (OB2C) combinatorial library platforms for cancer researchers to screen thousands to millions of
diverse molecules in a high throughput fashion against a variety of targets such as cancer cells, T cells,
cancer-associated proteins, antibodies and exosomes. The OBOC and OB2C libraries provided by the
CCCBSR cover various classes of chemical which include peptides containing unnatural amino acids,
peptidomimetics, peptoids, peptide nucleic acids (PNAs), macrocycles and small molecules; thereby meeting a
variety of scientific needs. These powerful combinatorial library methods not only offer great potential for
facilitating the drug discovery process but also provide powerful tools for basic research in various disciplines.
These methods enable investigators to generate and screen large numbers of chemical compounds that can
be used as valuable sources for the discovery of drug leads, molecular imaging agents, and capturing agents
for molecular biomarkers. For basic research, large collections of chemical compounds can be used to probe
their effects on specific cellular function. Compounds that elicit or suppress a specific cellular response can
then be identified and used as reagents to study cellular pathways involved in these cellular functions. The
CCCBSR also provides rapid lead optimization via combination of combinatorial library approach and standard
medicinal chemistry techniques to members of the UC Davis Comprehensive Cancer Center (UCDCCC).
Oversight and management of the CCCBSR is provided by the Director, Kit Lam, MD, PhD, an expert in
clinical, biochemical, and industrial experiences which are highly relevant to clinical translational research; and
the co-Director, Ruiwu Liu, PhD, an expert in organic and peptide synthesis, and multi-step synthesis of
natural products and derivatives. The CCCBSR will provide hands-on technology training to resource users
and offer timely technical support for their projects. The Specific Aims for the CCCBSR are to: 1) Provide pre-
made OBOC and OB2C combinatorial libraries. 2) Design, synthesize, and screen custom-made OBOC and
OB2C combinatorial libraries. 3) Screen the premade OBOC and OB2C combinatorial libraries synthesized in
the CCCBSR. 4) Determine chemical structure of the positive hits containing both natural and unnatural α-
amino acids by microsequencing or mass spectroscopy. 5) Re-synthesize compounds (peptides, peptoids and
small molecules) in on-bead or soluble form for in vitro and in vivo evaluation. 6) Provide telodendrimer-based
nanomicelles for nanoformulation and in vivo delivery of hydrophobic drugs. 7) Provide polyvinyl alcohol (PVA)-
based nanoplatform with the capacity for covalent drug loading. 8) Provide genetically encoded small illuminant
(GESI) technology platform for real-time functional cellular imaging. 9) Provide instrumentation and support for
high performance liquid chromatography (HPLC) analysis and purification.